Immune Outcomes to Neonatal Antigen Delivery in the Intestine

PROJECT ABSTRACT
The intestinal lumen contains a plethora of proteins from the diet and microbiota that require tolerogenic
responses. If tolerance is not properly mounted against these innocuous proteins the mucosal immune system
constantly encounters, individuals become progressively at-risk for inflammatory disorders including food
allergies or inflammatory bowel diseases. As these disorders increase in incidence, particularly within the
pediatric population, understanding how the immune system encounters luminal antigens during early life must
be thoroughly explored for the prevention and treatment of these disorders. Currently, exclusive breastfeeding
is the recommended dietary practice for infants through the first three months, followed by complementary
breastfeeding with introduction of solid foods. Yet the world health organization estimates only 30% of infants
globally are exclusively breastfed in the first three months, and alternative diets ranging from infant formula to
goat’s milk are used for a variety of reasons. Breastfeeding is significantly associated with decreased risk of food
allergy and IBD, and a number of beneficial components of breast milk have been identified. We have previously
shown epidermal growth factor (EGF) is highly concentrated in breastmilk, particularly early in lactation.
Immediately following delivery, EGF inhibits antigen delivery within the neonates intestine, and a lack of dietary
EGF is associated with increased intestinal permeability. As the infant ages, EGF in breastmilk decreases
allowing antigen delivery to occur and FoxP3+ regulatory T cells develop in response to orally derived antigens
during this time. Thus, maternal EGF regulates antigen delivery until a time when the infant is prepared to
develop tolerogenic responses to encountered antigen. Our preliminary data shows decreased dietary EGF or
disrupting the Epidermal Growth Factor Receptor within intestinal cells of the neonate resulted in early antigen
delivery, decreased FoxP3+ regulatory T cells at the time of weaning, and an increased predisposition to
intestinal inflammation in a model of colitis. Interestingly, while FoxP3+ regulatory T cell differentiation was
initiated in response to early antigen delivery, these cells eventually lost FoxP3 expression but remained in the
intestine, becoming effector cells. Antigen delivery was also associated with an increase in CX3CR1+ F4/80+
antigen presenting cells, however the role neonatal antigen presenting cells downstream of antigen delivery
remains unknown. These data suggest early antigen delivery in the absence of maternal EGF regulation disrupts
oral tolerance during early life. Here we will 1) determine the effect of neonatal antigen delivery on antigen
presenting cells in the colon and 2) determine the mechanism through which neonatal antigen delivery abrogates
regulatory T cells. This work has important implication in why antigen delivery during early life is regulated by
breast milk, and the consequences of early antigen delivery in the absence of maternal regulation.

Public health relevance
LAY SUMMARY The immune system must build tolerance to proteins in the intestinal lumen for life-long health and to avoid inflammation against the microbiota or dietary products. This process is regulated by components in breastmilk, yet only 30% of infants globally are exclusively breastfed for the first three months. This grant explores how immune responses are mounted toward dietary products in the absence of maternal milk and if those responses result in inflammation later in life.